University of New Mexico Center for Metals in Biology and Medicine

SUMMARY
Inorganic metals have long been a focus of biomedical research in New Mexico, largely due to the extensive
history of hard-rock mining of uranium, copper, and other mineral ores throughout the southwestern United
States. Heavy, rare earth, and transition metals exhibit nutritional, biomedical, and toxicological characteristics;
however, the molecular and cellular interactions are often incompletely understood, limiting our ability to
assess risks of toxicity, as well as exploit unique metallic properties for improved drug delivery or novel
medicinal applications. At the University of New Mexico Center for Metals in Biology and Medicine (UNM
CMBM) our goal is to link a molecular-level understanding of metal interactions with biomolecules to address
questions related to medicine, nutrition, and toxicology. UNM CMBM combines expertise in inorganic
biochemistry, complex tissue modeling/characterization, and metal mixtures toxicology with the comprehensive
analytical chemistry instrumentation in our Integrative Molecular Analysis Core (IMAC) to add sophistication
and augment the translational value of our Center members' and Research Project Leaders' research. The
UNM CMBM leadership has committed to world-class mentoring for early-stage faculty and trainees. Analytical
instrumentation and expertise within the IMAC have fundamentally transformed the UNM research ecosystem
and dramatically invigorated our vision for future research. Our long-term goal is to establish a nationally
recognized Center of Excellence uniting innovative researchers in the field of metals toxicology and
biomedicine that leads to positive impacts on southwestern communities and addresses global health issues.
The first objective of the UNM CMBM is to continue to build a strong community of independent – but
collaborative – investigators with common research goals related to metals in medicine and biology. We have
established a culture of support applying strategic mentoring, collaboration, and team science initiatives that
enhances RPL development as scientists, collaborators, and leaders. The second objective is to grow
capacity and capabilities of our innovative Integrative Molecular Analysis Core Facility (IMAC). The IMAC will
continue to advance contemporary analytical chemistry within the UNM research ecosystem, with an emphasis
on the innovative platforms and service. Our last objective involves advancing a leading Center of Excellence
in the multidisciplinary field of metals in biology and medicine that motivates impactful T0-T4 translational
research. We will take advantage of training and collaborative resources within the UNM HSC for clinical and
translational science and community outreach, which will provide center members with opportunities to
increase the impact of their bench research to clinical applications and community interventions. The
successful implementation of these aims will lead to growth in independent research funding at UNM,
especially among early-stage investigators. The outcomes of our program have clear benefit to clinical
populations and underserved communities in the Southwest.

Public health relevance
NARRATIVE Inorganic metals have long been a focus of biomedical research in New Mexico, largely due to the extensive history of hard-rock mining of uranium, copper, and other mineral ores throughout the southwestern United States. At the University of New Mexico Center for Metals in Biology and Medicine (UNM CMBM) our goal is to link a molecular-level understanding of metal interactions with biomolecules to address questions related to medicine, nutrition, and toxicology. Our long-term goal is to establish a nationally recognized Center of Excellence uniting innovative researchers in the field of metals toxicology and biomedicine that leads to positive impacts on southwestern communities and addresses global health issues.